Pharmacological Sciences Training Program

Summary
The mission of our Pharmacological Sciences Training Program (PSTP) is to train a diverse cohort of students
who contribute both to the development of medicines and become leaders in careers that span the entire
biomedical workforce. Among our objectives for achieving that mission are that students develop a broad
understanding of pharmacological sciences, and complementary skills in computation, communication, and
critical thinking. Building on traditional strengths in receptor biology, signal transduction, and neuropharmacology,
we have grown to include expertise in emerging areas of pharmacology, including immune regulation, RNA, and
ubiquitin systems. Our training faculty leverage cutting-edge experimental methods, including genomics,
proteomics, functional genetics, cryo-electron microscopy, optogenetics, high-resolution imaging and
mathematical modeling. Collectively, this provides an exceptional training environment for students. We take part
in a large umbrella program, referred to as the Biological and Biomedical Sciences Program (BBSP), which
oversees recruitment and training of ~110 first-year graduate students in the biomedical sciences. This training
includes instruction in methods to enhance reproducibility and the responsible conduct of research. BBSP
students carry out three research rotations before selecting a thesis lab and degree-granting PhD program at
the end of their first year. A strong Medical Scientist Training Program (MSTP) also brings in ~10 students per
year. Students who join the PSTP choose from our 65-core training faculty, who are productive, well-funded, and
universally committed to student mentorship. Faculty take part in formal mentor training and rely on evidencebased
practices to help students achieve their goals. The PSTP utilizes a complementary set of training
approaches, which combined, prepare students for future success, irrespective of their career choice. Students
take part in courses that cover the principles of pharmacology, as well as specialized electives. Rigorous scientific
writing and presentation courses develop skills in scientific communication. Quantitative skills are developed
through an emphasis on biostatistics, computation, and ligand- receptor binding theory and analysis. Rigor and
reproducibility are emphasized across all training approaches. Individual Development Plans are drafted by all
students, and a robust advisory system oversees their research progress. Students have many opportunities,
including internships, to explore diverse career options. Programmatic surveys gauge student satisfaction and
help to identify places for improvement. Students are appointed to the training grant for two years, during their
second and third year. The average time-to-degree is ~5.3 years and our PhD attainment rate is 90% over the
past 15 years. Over the last few years, the size of our Program has grown considerably. We have recently
recruited ~17 students into our Program each year, a trend we expect will continue. Our applicant pool, and the
class of matriculating students, is larger and more diverse than at any time in our history. Thus, our Program is
vibrant and growing, and this is due, in part, to the continued success of our T32 training initiatives.

Public health relevance
Project Narrative Students who complete this predoctoral training program will acquire comprehensive knowledge related to the principles of pharmacology and deep understanding of a specific research question relevant to human health. They will develop essential skills in critical thinking, data analysis, written and oral science communication, and quantitative methodologies. These students will be poised to contribute to a myriad of scientific careers in biomedicine throughout academia, government, or industry.